CORE--TAILORED MESSAGE

The primary activity of the Tailored Message Core (TMC) will be to work closely with each of the three projects to develop tailored print materials that satisfy the requirements of the individual projects. To achieve this aim, the TMC will work with project investigators and staff in: * Developing the questionnaires used in collecting data for tailoring; * Developing the algorithms for identifying messages for use in the tailored materials; * Developing the graphic elements of the tailored materials; * Developing the computer programs required for high speed data collection, tailoring and printing; and * Mailing the tailored materials to subjects. Centralizing development of the tailored print materials for the three projects in the TMC provides distinct advantages in equipment, personnel and quality over having each project develop and manage their own tailoring system. Tailored print materials for each project will be subjected to a carefully orchestrated development and production cycle with quality assurance procedures build into each step. Organizing a multidisciplinary team under one roof enables daily interaction between programmers, content experts, behavioral and educational experts, graphic designers and writers.